Unlocking the Therapeutic Potential of the Veratrum Alkaloids

Project Summary/Abstract
Chronic pain is a debilitating condition suffered by a consistently large percentage of the global population.
Current treatment options such as opioids suffer from undesired side effects, including high risk of addiction.
Natural products have gained considerable attention from the pharmaceutical industry as non-opioid alternatives
for treating pain, including neurotoxins such as tetrodotoxin and saxitoxin. These alkaloids work by blocking
voltage-gated sodium channels, preventing the firing of action potentials and transmission of pain signaling. This
represents a non-euphoric and non-addictive strategy for treating pain. One family of neurotoxic natural products
that remain underexplored by the pharmaceutical industry are the Veratrum alkaloids. Veratrum, the genus of
flowering plant these steroidal alkaloids are isolated from, has a long history of use in traditional Chinese
medicine as an analgesic. Biological evaluation of its constituent natural products has been significantly
hampered by low isolation yields from plant material, making laboratory synthesis the most reliable route to
obtaining sufficient quantities of the compounds for thorough pharmacological evaluation.
The proposed research project concerns the total synthesis of several Veratrum alkaloids that have thus far
evaded laboratory preparation: the highly analgesic veratravine D and veratravine E and the partially-saturated
D-ring congener hosukinidine (Aim 1). Each of the proposed syntheses utilizes common intermediates from the
recently completed Trauner group total synthesis of veratramine and 20-epi-veratramine and features an
intramolecular, transition-metal-catalyzed Diels–Alder reaction for the construction of the steroidal D-ring. The
proposed research project also concerns the evaluation of the previously prepared veratramine and 20-epi-
veratramine, along with the natural products prepared in Aim 1, across a variety of ion channels implicated in
pain signaling to definitively establish their analgesic mechanism-of-action (Aim 2). This will primarily be
accomplished by transfecting cells with the genes encoding the relevant channel and performing whole-cell patch
clamp electrophysiology in the presence of the natural products. Targets that will be evaluated include Nav1.7,
NaV1.8, CaV2.2, and TRPV1 channels. Molecular docking will be performed to rationalize the observed biological
activities. The work will be completed in the University of Pennsylvania Department of Chemistry and Perelman
School of Medicine, where the sponsor Prof. Dirk Trauner has joint appointments. The Trauner laboratory has
extensive experience in both natural product total synthesis and neuropharmacology, with all of the relevant
instrumentation and equipment to conduct research in either field. The project will allow the applicant to continue
to refine his abilities in synthetic organic chemistry, as well as acquire new skills in patch clamp electrophysiology,
cellular biology, and molecular docking.

Public health relevance
Project Narrative: Neurotoxic natural products that inhibit the signaling of voltage-gated ion channels have garnered considerable attention from the pharmaceutical industry as non-opioid analgesics. One class of neurotoxic alkaloids that are still fairly unexplored are those found in the flowering plants of the genus Veratrum, due in part to their structural diversity and synthetic complexity. The Trauner group has recently completed a total synthesis of the Veratrum alkaloids veratramine and 20-epi-veratramine that can be utilized to access several other naturally occurring Veratrum alkaloids and to thoroughly evaluate the therapeutic potential of this class of molecule.